Administrative Core

Project Summary – Admin Core
The administrative core will promote interaction among researchers and clinicians at Cincinnati Childrens, UC
and Cedars with interest in CF/CFTR related research. The implementation of this thematic program,
Personalized Medicine in CF, particularly people with CF who are Black and Hispanic, experience unique
challenges and often have poorer outcomes compared to Caucasians, will be an important goal. Toward this
end, the Core will develop a strategic plan; oversee the operations at the Center including budget, core services,
the P/F Program, enrichment programs, and membership management. The administration will help shape an
excellent research environment for CF/CFTR-related studies by promoting and fostering collaboration between
the basic, translational, and clinical investigators. The Administrative Core will provide support to three
biomedical cores for their facilities and services and will be proactive in developing patient outreach programs.
The ultimate goal is to develop personalized therapy for individuals with CF to improve their quality or life and
wellbeing.